Mechanosensitive determinants of podocyte physiology

Project Summary
Kidney podocytes operate under substantial biomechanical stress as part of their physiological function to filter
plasma. They have a specialized dynamic actin cytoskeleton structure to reinforce the fragile foot process
morphology that is required for their function. Using in vivo proteomic screening and mining of NephroSeq data,
we have identified nebulette as a novel scaffolding protein that may play a role in organization and
maintenance of the podocyte cytoskeleton and adhesion. Nebulette is an actin-binding protein expressed
highly in the heart; mutations on its nebulin repeat domains have been linked to abnormal cardiac
biomechanics and dilated cardiac hypertrophy. We hypothesize that nebulette plays a critical role in stability of
actin filaments in kidney podocytes, increasing their biomechanical resilience against injury. We will test this
hypothesis in vitro and in vivo using cultured primary podocytes and podocyte-specific nebulette knockout mice,
respectively. We will use high-content imaging to characterize morphological changes associated with
nebulette ablation and live-cell microscopy to determine its effects on cell motility and calcium dynamics. We
will also quantitatively characterize cytoskeletal biomechanics using atomic force microscope elastography. We
will then use proteomics and network analyses to construct a spatially specific partial differential equations-
based dynamical model to quantify contribution of different biphysical components of nebulette in cytoskeletal
stability and focal adhesion distribution and function. This in silico process will also identify likely drug targets
that may modulate podocyte mechanobiology in a cell-specific manner. We will finally test the contribution of
nebulette to in vivo podocyte physiology using two different disease models in podocyte-specific nebulette
knockout mice. Through these experiments and computational modeling, we will thoroughly characterize the
role of nebulette in glomerular physiology, and potentially identify novel pathways to modify biomechanical
resilience of podocytes under healthy and disease conditions.

Public health relevance
PROJECT NARRATIVE Kidney podocytes play an important role in kidney filtration. In order to perform this key biological function, the podocyte has to maintain a specialized structure that depends on a number of proteins. We identified a previously unknown protein, called nebulette, as a key component of the podocyte filtration machinery, and we propose to test its role in maintenance of the specialized structure of podocytes during health and disease. Our results will improve our understanding of podocyte biology and may identify new drug targets to treat kidney diseases such as diabetic nephropathy.